Administrative Core

The purpose of the Administrative Core is to provide the leadership and administrative management for the proposed multidisciplinary P50 SPORE aimed at capitalizing on the infrastructure at the University of Hawai`i Cancer Center (UHCC) and the cancer rate differences among populations of its catchment area to conduct translational research addressing the population differences in cancer risks and outcomes that exist in Hawaiʻi and the Pacific. The Administrative Core will build upon a number of UHCC resources, both administrative and scientific, to foster the implementation and coordination of the research in this P50. This Core will also closely coordinate the P50 resource-building and career-development activities with those implemented by UHCC, so greater efficiency is achieved at our cancer center level. Thus, this Core serves major administrative and integrative functions for the grant. The P50 will rely on an Internal Advisory Committee (IAC), consisting of key senior basic and clinical researchers, to receive input on research opportunities and to facilitate coordination with potentially synergistic local initiatives. The program will also benefit from the input of a Catchment Area Advisory Board (CAAB) composed of leaders and patients with experience in cancer research and/or survivorship, and who will advise on the responsiveness of our activities to population needs and expectations. Program evaluation will heavily rely on the input of an External Advisory Board (EAB) composed of outside investigators who are leaders in SPOREs and/or cancer research and a nationally-recognized patient representative. Specific Aim 1 will be to provide the overall scientific and administrative coordination and joint leadership for the P50 grant. Specific Aim 2 will be to coordinate and integrate the P50 activities with those of UHCC. Specific Aim 3 will be to plan and evaluate current and future translational research on cancer as part of the P50 SPORE program. The Administrative Core will play an essential role in supporting the research program proposed in the P50. We believe that the skills and experience of each Core Co-Leader and the proven approaches described in this section will provide both the foundation and the building blocks to achieve our goals.